Antibody targeting of the virome

PROJECT ABSTRACT
While the microbiota has emerged as an important aspect of mammalian health, the vast majority of
current studies have focused on the bacterial component of the microbiota, despite the presence of
fungi, archaea and viruses. The virome has recently just begun to become characterized and while
there are eukaryotic viruses present within a healthy individual, the overwhelming majority of the
viruses on the human body are bacteria infecting viruses called bacteriophages (phages). Changes
in these phage communities have been reported in animal and humans during a variety of diseases
including inflammatory bowel disease and obesity, however we known very little about these
populations during the healthy state. Our recent work has demonstrated that bacteriophages, despite
being unable to actively infect mammalian cells, are capable of inducing immune system
development. These data suggest that bacteriophages represent an unappreciated microbe that is
capable of shaping immune system responses. Recent studies on the bacterial component of the
microbiota, have revealed that identifying what bacteria the immune system reacts to, can provide
insight into specific bacteria that influence disease, novel biomarkers and unique antigens that can
influence natural immune system development. However, this has yet to be performed with the
virome. Antibodies, including IgA and IgG, and are highly abundant at mucosal surfaces and sera,
respectively and are known to have high reactivity to commensal bacteria. We present data within
this application that both sera and mucosal antibodies have high reactivity to commensal
bacteriophages in both humans and mice. Based on this, we propose to characterize and identify the
commensal viruses that are targeted by IgA and IgG. We will propose three distinct aims. Aim 1 will
catalog the mucosal IgA/IgG reactivity against commensal viruses from stool samples obtained from
healthy humans. To do this, we have optimized a strategy to purify and sort viral particles allowing
us to capture IgA bound DNA and RNA viral particles. As sera antibody reactivity can often reveal
unique commensal organisms of interest, Aim 2, will characterize the sera reactivity against the gut
resident viral communities using paired sera and stool samples from humans. Finally, to understand
how antibodies can influence these human associated viral communities, Aim 3 will utilize gnotobiotic
mice that lack adaptive immunity and IgA and colonized with healthy human microbiota to understand
how viral communities are controlled by mammalian immunity. These studies will be the first to
catalog how the human immune system reacts to commensal viruses of healthy human intestine and
will provide a rich resource of data that has the potential to identify novel viruses of interest and
establish paradigms how the immune system establishes homeostasis with the resident viral
community.

Public health relevance
PROJECT NARRATIVE Understanding how the immune system is able to interact with the organisms that live on our body has revealed unique immune-microbe interactions that are now known to influence mammalian health. This has yet to be done with our resident viral community. Our proposal will be the first to catalog and identify what commensal viruses interact with antibodies in humans, which has the potential to identify novel viruses that are relevant to human health and will facilitate future mechanistic studies.